OTHER FUNCTIONS: PHASE I SBIR CONTRACT, DRIVING UNDER THE INFLUENCE OF DRUGS DAS

To identify available data relevant to drugged driving, gaps in this data, and intended uses of data through formal consultation with expert stakeholders.